BIOMEDICAL COMPUTING, ANALYTIC, AND DATA MANAGEMENT SERVICESTASK ORDER TITLE: NCCIH INTEGRATED INFORMATION SERVICES PROGRAM

Through this contract the National Center for Complementary and Integrative Health (NCCIH) seeks support for the operation of an integrated information services program to inform the public, health care providers, researchers, scientists, and other key stakeholders about NCCIH and complementary and integrative health research at the National Institutes of Health (NIH). NCCIH is one of 27 Institutes and Centers that comprise the NIH and is the lead Federal agency for research on complementary and integrative health approaches. The Center’s mission is to define, through rigorous scientific investigation, the usefulness and safety of complementary and integrative health interventions and their roles in improving health and health care.

Dissemination of health information is also a key part of NCCIH’s mission as well as the Congressional language that established the Center, thus NCCIH seeks a contractor who can support an information services program that offers a seamless interface between content development, delivery, and evaluation. This information services program requires the synergistic operation of several interlinked components and activities, including, but not limited to, an Information Clearinghouse; the NCCIH websites; content creation for consumers and other key stakeholders; outreach, marketing, and promotion; and evaluation. The NCCIH website (https://nccih.nih.gov) is the primary method of delivery of content while other key delivery channels include, but are not limited to, social media platforms, the Information Clearinghouse toll-free line, public inquiries, media relations, exhibit and outreach programs, and the NCCIH Intranet staff website. The Contractor will be responsible for the day-to-day management of NCCIH’s Integrated Information Services Program, including the Information Clearinghouse and NCCIH websites, under the direction of NCCIH’s Contracting Officer’s Representative (COR) and web managers in the NCCIH Office of Communications and Public Liaison (OCPL).